3D Structure and Function of Ligand-Gated Ion Channels

Project Summary
Our nervous system relies on the transmission of signals from one nerve cell to another. The primary
mechanism by which this occurs is via the release of neurotransmitter from the presynaptic nerve cell, binding
of the transmitter to receptors, primarily located on the postsynaptic nerve cell, and opening of
neurotransmitter-gated receptors, transforming the chemical signal of the neurotransmitter into an electrical
signal in the postsynaptic neuron. Glutamate is the major neurotransmitter in the nervous system and
glutamate receptors mediate most of the so-called ‘fast’ or sub second, neurotransmission. Over the past 3
decades, we and other researchers have revealed the overall structure and mechanism of AMPA, kainate and
NMDA receptors. There are a large number of structures of receptor domains and full-length receptors and this
structural information, in combination with biophysical, computational and biochemical studies has illuminated
the mechanism(s) by which the binding of neurotransmitter results in the receptor transiting multiple
conformational and functional states, including the open, ion conducting conformation. However, nearly all of
the structural studies on glutamate receptors have involved the use of recombinant assemblies, sometimes
with multiple modifications, produced in heterologous expression systems. Because AMPA receptors, in
particular, assemble with a large number of auxiliary subunits, many of which modulate the activity of the
receptor, it has proven difficult, if not impossible, to recapitulate the assembly of native-like receptor complexes
in a heterologous expression system setting. A major goal of the research proposed in this application is to
isolate native, or endogenous, receptor complexes from brain tissue, thus allowing us to elucidate the
structure, and probe the function, of bona fide native receptor assemblies. To do this, we have developed an
ensemble of receptor subunit specific antibodies that allow us to capture particular receptor assemblies, thus
enabling, for the first time, capture of the AMPA receptor, GluA4-containing receptor from the cerebellum, a
key receptor assembly implicated in motor learning and behavior. We have further employed a monoclonal
antibody to capture the elusive GluN3A subunit containing NMDA receptor, allowing us to elucidate the subunit
stoichiometry of native GluA1/Glu3A receptors and setting the stage for the structure determination of the
receptor complex, in multiple functional states. Lastly, there is little knowledge, at the nanometer resolution, of
how receptors are organized at synapses. To address this question, we have employed mouse models, gold
particle-labeled antibody fragments, and cryo-electron tomography, to map the localization of AMPA and
NMDA receptors at glutamatergic synapse, thus showing how the receptors are clustered, relative to
presynaptic vesicles, and enabling the reconstruction of AMPA receptor assemblies in situ. Our work, overall,
will elucidate the molecular assemblies and mechanisms of endogenous receptor assemblies, thus illuminating
the principles by which the receptors function in the context of endogenous synapses.

Public health relevance
Project Narrative Nerve cells communicate largely by way of signaling at chemical synapses, where a released neurotransmitter is detected by receptors on neighboring cells, initiating electrical and chemical signaling pathways. Signaling at chemical synapses is essential for the normal development and function of the nervous system, for learning and memory, and is implicated in many neurological diseases. The proposed research will illuminate the structure and function of neurotransmitter receptors and their organization at chemical synapses.